The Early Growth and Development Study Cohort of the ECHO Program

Project Summary
The combined economic and personal effects of children’s neurodevelopmental problems, such as conduct
disorder, ADHD, and depression and anxiety symptoms are substantial. At the same time, there is growing
evidence that dimensions of positive health can support children in leading meaningful, productive lives. In the
current proposal we address knowledge gaps related to the timing of psychosocial environmental exposures
and when their effects on child neurodevelopment and positive health emerge, and at what ages children’s risk
factors and assets are most potent in affecting developmental trajectories. We also propose to examine the
transition to adolescence. Adolescence can be a turning point in child development given rapid changes in the
brain, emotional, and social system, yet longitudinal studies from infancy to adolescence with large cohorts of
children from diverse backgrounds are sorely lacking. Last, children’s neurodevelopment and positive health
are rarely examined in concert, leading to incomplete assessments of children’s mental health at all phases of
development. This application seeks to fill some of these knowledge gaps through participation in the
Environmental influences on Child Health Outcomes (ECHO) Cohort Study Sites for Pediatric Follow Up
Program. In this application, we propose to follow an existing sample of 1,000 children from the Early Growth
and Development Study (EGDS) cohort who are enrolled as Level 2 participants in the ECHO Program and
have ECHO Cohort Protocol data elements beginning in the prenatal period. EGDS is a nationwide sample of
children living with either their adoptive or biological parent(s). Children will be age 7 – 20 years old and
assessed annually using the ECHO Cohort Protocol in the proposed study. We have been highly successful in
achieving our planned recruitment and enrollment rates, collecting and sharing data with the ECHO Program,
and contributing to ECHO-wide science and manuscripts in the current ECHO funding cycle. We will build on
our successes and infrastructure to contribute to ECHO’s goals through leading collaborative ECHO Cohort
science, with a dual focus on ECHO Cohort Protocol core data elements and on two specialized child outcome
areas: Neurodevelopment and Child Positive Health. Through three specific aims, we will: (1) leverage ECHO
Cohort Protocol core data elements to examine the immediate and latent impact of early exposures on child
health outcomes across different developmental periods in diverse contexts; (2) leverage data from specialized
outcomes to test predictors of change in neurodevelopment and positive health in adolescence; and, (3)
implement data-driven check points every quarter to assess our retention of existing cohort participants, with
an emphasis on diversity and implementation of the protocol with high fidelity. Our overall goal is to work
collaboratively with the ECHO Program to advance the understanding of predictors and outcomes of child
health in order to inform programs, practices, and policies that will improve the health of children for
generations to come.

Public health relevance
8. Project Narrative The psychosocial environment is known to be associated with the unfolding of child health outcomes beginning very early in development, yet questions remain about the specific mechanisms linking psychosocial exposures and child health outcomes, and the calibration of the timing linking an exposure with an outcome. The proposed study adds to and extends the ECHO program by conducting annual assessments of our current ECHO cohort children thru age 20. When combined with other ECHO cohort data, this study will enable an in depth look at how adolescence can be a pivotal period in development for studying the timing of the effects of early psychosocial exposures and testing outcome-specific models that determine whether early psychosocial exposures have longer-term effects, latent or delayed effects, and/or desisting effects.